Training in Aging Research

Summary
This 5th competitive renewal application for an Institutional T32 training grant is made possible due to an
outstanding base of aging research, funded mainly by the NIA at the Albert Einstein College of Medicine and
Montefiore Health System. Included as the bedrock for this grant are the following programmatic features:
Einstein Nathan Shock Center of Excellence in Basic Biology of Aging (E-NSC, an NIA-funded P30), the Paul
Glenn Center for the Biology of Human Aging (E-Glenn), a hugely popular graduate course in the Biology of
Aging developed specifically for this grant, a very successful hackathon that we instituted for the purposes of
rigor and reproducibility training. Existing grant support for several aging research Programs (3 P01s and a U19)
and significant growth in individual R01 awards show the success of our pool of training faculty. Einstein
continues as a source of mentees, delivers collaborative environments, and fosters interactions with research
gerontologists. Within this collaborative environment lies a strong emphasis on research on the biology of aging
founded upon a diverse group of well-funded mentors, who in turn have access to a diverse pool of potential
trainees. Our training program is built on successful and innovative programmatic and thematic areas of aging
research. We are proud that 82.5% of our previous trainees from the past four training cycles continue in
research-related endeavors, and the data tables in this proposal showing a continuing pool of highly qualified
eligible trainees. Our T32 program has been a success to date based on the quality of candidates, their scientific
and academic achievements, and the number of minority individuals trained. Because of our growth as an aging
Center, we are requesting to continue with three predoctoral and three predoctoral slots, as well as one flexible
slot to strategically fill out our roster with the most exceptional candidates available, irrespective of pre- or
postdoc status. We continue including MSTP students in our program, and their time to complete the PhD has
remained consistent, showing the feasibility of their participation in our T32. With our responsive evaluation
program in place, we have made changes such as increasing our co-mentoring program and adding a highly
qualified Co-Director, Dr. Derek Huffman; shortening training periods for trainees who are not performing well to
make the most of our investment; budgeting for a hackathon to follow up on the success of the previous ones,
and maintaining the popular informal lunch meetings with the Director and Co-Director. Thus, our T32 predoctoral
and postdoctoral training program continues to give participants state-of-the-art research training, exposure to
diverse investigators and fields of expertise in the biology of aging, enabling them to embark on successful
careers involving research in aging and aging-related diseases.

Public health relevance
Narrative This T32 training grant continues to successfully train the scientists of tomorrow in aging research at Einstein. This success is based on the quality of candidates, their scientific and academic achievements, the percent of trainees who have stayed in research, and the number of minority individuals trained. Within our highly collaborative environment lies a strong emphasis on translational research from a diverse group of mentors who are well-funded and who have access to a diverse pool of well-qualified trainees. We continue the Biology of Aging class developed specifically for this grant and our highly successful hackathon to teach rigor and reproducibility, while also adding new and diverse mentors and activities to enrich the training experience.